Neuropathology Core

NEUROPATHOLOGY CORE - SUMMARY/ ABSTRACT
For the past 35 years, the UCSD-ADRC Neuropathology Core has been instrumental in providing support
for establishing the accuracy of clinical diagnosis of Alzheimer's Disease (AD) and dementia with Lewy bodies
(DLB), delineating structural and clinico-pathological correlates of dementia in AD, identifying new
neuropathological entities causing dementia, providing tissues to investigators and helping to better
understand the mechanisms of synaptic and other aspects of neurodegeneration in AD. For the renewal there
will be 6 Aims of the Neuropathology Core: 1) perform rapid autopsies and procure brains from the ADRC
participants, using a standardized protocol; 2) perform standardized neuropathological diagnoses and
immunocytochemical analysis of demented and normal aged (control) patients clinically evaluated by the
UCSD ADRC following the new NIA criteria; 3) perform clinical neuropathology assessments on brain, spinal
cords and eyes from postmortem material from ADRC participants using best practice (NIA-AA) guidelines.
Perform immunochemical analysis relevant to neurodegeneration and synapse loss in MCI and early AD
cases; 4) maintain a state of the art brain repository to provide the ADRC projects and other investigators with
well characterized including early AD and MCI cases; 5) foster the utilization of the ADRC Neuropathology
tissue repository for new research and inter-center collaborations. Approximately 50 to 60 cases and over 100
tissue requests are processed a year. The neuropathological results will be submitted to the National
Alzheimer’s Coordinating Committee (NACC) in compliance with NIA requirements. As part of the mission of
the Core we will also continue to support extensive collaborations with national and international investigators
and train fellows, residents, graduate and undergraduate students in neuropathology and microscopy
techniques. With the ADRC Outreach, Recruitment and Education (ORE) Core organize meetings to
encourage the use of the neuropathology core; 6) Mentor young and minority investigators in neuropathology
and neuropathological research. We will foster the next generation of scientists by encouraging them to
conduct research with the postmortem tissues. We will continue to provide tissues to local and national
investigators and for multi-center initiatives such as the Genome-Wide Analysis Studies organized by NIA.